Reproductive Healthcare Deserts and Inequalities in Maternal and Infant Health

Project Summary/Abstract
Access to reproductive healthcare in the U.S. has become increasingly constrained. Although a growing body
of research has focused on identifying state-level policies that affect women's access to care, less attention
has been paid to documenting access to reproductive healthcare at the local level. Understanding how
individuals actually experience access to care necessitates a finer-grained measure than the state level,
although no data currently exist that would allow for such an approach. Local access to reproductive
healthcare, including contraception, maternity care, and abortion, is a key structural factor that can hinder or
facilitate women's reproductive autonomy and maternal and infant health. Therefore, the primary goal of the
proposed project is to create a new comprehensive longitudinal (2009-2021) dataset that will allow us to
identify spatial variation in access to contraceptive, maternity, and abortion care at the U.S. county-level. We
will use the new dataset to identify “reproductive healthcare deserts” (RHD), or counties where access to
contraceptive, maternity, and abortion care is severely limited or nonexistent, document how access has
changed over time, identify disparities in access, and examine how such disparities shape health outcomes. To
create this unique dataset, we will integrate data sources on (a) access to publicly funded contraceptive care at
Title X clinics from the Office of Population Affairs and at Federally Qualified Health Centers from the Centers
for Medicare & Medicaid Services; (b) access to maternity care from the Health Resources and Service
Administration; and (c) access to abortion care from the Myers Abortion Facility Database. We will also create
an interactive dashboard that will map the RHD dataset and include time-varying county-level
sociodemographic characteristics obtained from supplementary datasets (e.g., American Community Survey).
The dashboard will guide our descriptive research into the spatial patterns and scale of changes to
reproductive healthcare access over the study period and highlight disparities in access and their overlap with
sociodemographic traits. We will merge the RHD dataset with restricted-use data from the National Vital
Statistics System and the National Survey of Family Growth to develop spatially clustered multilevel models
analyzing the relationship between county-level reproductive healthcare access and individual-level measures
of maternal morbidity, infant health, interbirth intervals, contraceptive use, and unintended birth. Each of these
outcomes is tied to women's ability to time, space, and limit births and therefore likely to be affected by their
level of access to reproductive healthcare. Taken together, this project will provide a new comprehensive
measure of reproductive healthcare, a novel dataset and interactive dashboard that will track changes over a
13-year period, and robust evidence of how reproductive healthcare deserts are related to reproductive
autonomy and maternal and infant health.

Public health relevance
Project Narrative This project will identify disparities in access to reproductive healthcare at the U.S. county level from 2009- 2021. This will be the first project to measure reproductive healthcare deserts, or areas where access to reproductive care is limited or nonexistent, and to document the relationship between access to reproductive healthcare and reproductive autonomy and maternal and infant health. This information will allow researchers, policymakers, and practitioners to better understand areas of need and to address inequalities in access to reproductive healthcare by race/ethnicity, socioeconomic status, and rurality.